Modeling Metastasis and Acquired Drug Resistance Using Circulating Tumor Cells

PROJECT SUMMARY
Advanced hormone receptor positive (HR+) breast cancers, the most common subtype, are
initially responsive to multiple endocrine interventions, but they ultimately develop drug resistance.
Circulating tumor cells (CTCs) underlie the blood-borne metastatic spread of cancer, and they
also provide a noninvasive source to sample tumor cells during the course of therapy and acquired
resistance. Using a microfluidic enrichment technology that preserves CTC viability, we successfully
established a cohort of 15 CTC-derived longterm cultures from women with refractory HR+ breast
cancer. A subset of these shows the expected acquired ESR1 and PIK3CA mutations, confirmed in
matched metastatic tumor biopsies. However, the most common, and least well understood, correlate of
endocrine resistance is loss of estrogen receptor-α (ER) expression by cancer cells. In these cases,
cultured CTCs recapitulate ER silencing, and some are biphenotypic, with coexisting ER+ and ER-
subpopulations derived from the same patient. Single cell-derived colonies show that ER+ CTCs can
produce ER- progeny, pointing to likely epigenetic mechanisms and underlying cell plasticity. We
propose to investigate the epigenetic regulation of ER expression loss and its potential restoration,
using genomic analyses combined with CRISPR functional screens. In Aim 1, we will compare
chromatin landscapes of isogenic ER+ and ER- CTC subpopulations, define their distinct functional
properties and identify factors that modulate their interconversion in vitro. In Aim 2, we will use undertake
CRISPR screens to identify genes capable of restoring ER expression to CTC lines from HR+ breast
cancers that have lost endogenous ER expression following endocrine therapy. Preliminary data
indicate the feasibility of this approach, and we will explore mechanisms underlying restoration of
ER expression, and whether this is accompanied by a return to ER-dependent proliferation. Together,
these Aims address the plasticity of ER expression in patient-derived cultured CTCs that
recapitulate clinical treatment exposures and tumor adaptation mechanisms. Loss of ER expression in HR
+ breast cancer may also lead to dependence on alternative oncogenic drivers, that may be constitute
drug targets in refractory HR+ breast cancer. In Aim 3, we apply a chemical proteomic strategy in CTC
lines, combining cysteine cross-linking with mass spectrometry to identify all ligandable cysteine residues
within cellular proteins. Preliminary data show multiple cysteine-targetable proteins in CTCs that are not
present in untreated breast cancer lines, and we will use CRISPR screens to identify those required for
proliferation, followed by identification of tool compounds from a specialized library of cysteine-reactive
covalent inhibitors for functional analyses. Together, these complementary approaches address the loss
of ER expression in advanced HR+ breast cancers, with the goal of overcoming acquired resistance to
endocrine therapy.

Public health relevance
PROJECT NARRATIVE Advanced breast cancers of the most common type (Estrogen Receptor (ER) positive) initially respond to hormonal therapy, but then become resistant to further therapy. As they invade, breast cancers shed cells into the bloodstream (Circulating Tumor Cells; CTCs), which we have been able to culture repeatedly in the laboratory during the course of therapy, providing an exceptional resource to better understand acquired drug resistance. Using these patient-derived cell cultures, we propose to apply sophisticated functional genomic and chemical proteomic technologies to characterize and ultimately overcome the most common, and least well understood, mechanism of acquired resistance to hormonal therapy, namely the complete loss of ER expression in breast cancers that were initially ER positive.